Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The Administrative Core of the Washington University Center for Diabetes Translation Research (WU-CDTR)
will continue to successfully provide leadership in setting the overall scientific direction of the Center guided by
our strategic vision in which a health equity lens is the foundation for transformative diabetes research
translated into action and impact. Our Center mission is to be the nexus for transdisciplinary team science in
advancing the conduct of the next generation of diabetes translation research, and our goal is to build a rigorous,
scientific evidence base to inform dissemination, implementation, and sustainability of efficacious interventions
for populations at risk for diabetes disparities. The Administrative Core of the WU-CDTR builds on its success
to provide the structure for effective and efficient operation and maintenance of the WU-CDTR in compliance
with NIH and University guidelines. The Administrative Core coordinates and integrates all activities of the WU-
CDTR to help ensure approaches for enhancing diversity and inclusion and successful achievement of the
Center vision, mission, and goals. The WU-CDTR Director and Associate Directors, with governance and input
from the Executive Committee, are responsible for establishing the goals and direction of the Center,
coordinating committee meetings, managing the fiscal aspects of the Center, monitoring and documenting the
use of each Translational Research Core, preventing overlap in funding for services provided, managing the Pilot
and Feasibility Program, tracking publications that were facilitated by Center Cores, overseeing the Enrichment
Program, and reporting annually to the NIH/NIDDK. The Administrative Core ensures the WU-CDTR is well-
positioned as a resource for transdisciplinary team science, working to attract and retain early stage and senior
investigators with diverse backgrounds who are underrepresented in diabetes translation research through its
location at Washington University in St. Louis, its regional affiliation with the University of Missouri, and its
national affiliation with the Council on Black Health at Drexel University.
The specific aims of the Administrative Core are: (1) to provide the coordination, integration, organization,
and oversight for all WU-CDTR activities and components including Internal and External Advisory Committees,
Translational Research Cores, the Pilot and Feasibility Program, and the Enrichment Program; (2) to manage
and oversee criteria for WU-CDTR membership and a process for reviewing and updating
Center membership; (3) to coordinate WU-CDTR communication and interactions with the research base, cores,
committees, other centers, and NIH; (4) to manage and oversee the WU-CDTR website; (5) to manage and
oversee the use of WU-CDTR funds; and (6) to assess productivity, effectiveness, and appropriateness of WU-
CDTR activities, scientific opportunities, and areas of collaboration among Center members.